Development of Muc1 Vaccine for the Prevention of Pancreatic Cancer

The objective of this Statement of Work is to assess the cancer prevention efficacy of the Muc1 vaccine alone in hMuc1.p48Cre.LSLKras G12D and p48Cre.LSL-Kras G12D mice as follows.